Designing Hydrogels that Recapitulate Physiological Cell-Matrix Adhesions

PROJECT SUMMARY
Better model systems are needed to improve our understanding of how tissues develop, function, and
regenerate in order to design more effective biomedical therapies. Synthetic hydrogel matrices have been
widely used in these applications and have significant advantages as fully defined systems that can be tailored
to specific biomedical applications through the inclusion bioactive ligands within matrices having tunable
viscoelasticity. However, the extracellular matrix (ECM) that surrounds cells in tissues contains numerous
proteins and biopolymers that are dynamically modified by cells, and which aspects of cell-ECM interactions
are most important for recapitulating physiological adhesions is an area of active research. All adherent cell
types use both syndecans and integrins to mediate cell attachment to the ECM and measure the local
viscoelastic properties. However, most hydrogel systems are often functionalized with a single integrin-binding
RGD ligand covalently attached to the polymer network, which does not bind syndecans and cannot be re-
arranged by cells. We propose to develop a platform technology that can be used to better mimic cell-ECM
interactions found in tissues. This will be done by including dynamic ligands for both integrins and syndecans
within a hydrogel having tunable viscoelastic properties. We have developed a platform that utilizes
interpenetrating networks of covalent and multiplexed non-covalent polymers to enables us to independently
tune the mobility of multiple adhesion ligands in addition to both the stiffness and stress relaxation of the
hydrogel. We hypothesize that including dynamic ligands for syndecans will lead to cell-matrix adhesions that
better recapitulate those found in tissues, and this will increase osteogenic differentiation of human
mesenchymal stem cells within viscoelastic matrices. We will test this hypothesis in two aims. The First Aim
utilizes a multiplexed system containing multiple discrete self-assembling peptide nanofiber networks, each
which can be functionalized with ligands for either integrins or syndecans having tunable mobility. Different
ligand combinations and mobilities will be tested the number and size of focal adhesions will be quantified, in
addition to the extent of actin network formation. The Second Aim will utilize covalent and non-covalent
networks to tune the viscoelastic properties of the hydrogel to understand how syndecans and integrins
combine to transduce mechanical signals that drive cell behavior. We will culture hMSCs in gels having
different viscoelastic properties and ligand compositions to understand and quantify how dynamic syndecan
ligands increase osteogenic differentiation of hMSCs. The PI has significant experience designing dynamic,
viscoelastic hydrogel matrices to target specific cell-matrix interactions. This proposal will both help develop a
highly modular engineering platform that can be applied to a range of tissue systems, while also uncover
design rules for recapitulate physiologically relevant cell-matrix interactions within synthetic systems.

Public health relevance
PROJECT NARRATIVE Recreating the complexity and properties found in human tissues remains a challenge in bioengineering. This proposal uses a tunable hydrogel platform to form complex cell-matrix adhesion that include ligands for both the integrin and syndecan protein families. The ability of these materials to better recapitulate the extracellular matrix will improve our ability to model tissues in the lab and deliver effective regenerative therapies in the clinic.